Biological Methylation: Fundamental Mechanisms

Abstract:
The purpose of this R13 submission is to request funds to support a limited number of trainees, individuals
identifying as underrepresented minorities (URMs), junior investigator-invited speakers and those with family
caring responsibilities to participate in the 2024 FASEB Science Research Conference on “The Biological
Methylation: Fundamental Mechanisms in Health and Disease”. This will be the 15th FASEB SRC on Biological
Methylation and will be held at the Sheraton Porto Hotel from 28th July-1st August 2024. The last FASEB meeting
was held in Catania, Italy in 2022, where Dr. Davies and Dr. Ge were elected as co-chairs to work jointly with
Prof . Van Rechem and Prof. Strahl who will be the two co-organizers for 2024. The 2024 conference builds
upon the scientific excellence of previous meetings, bringing together a diverse group of cancer and
developmental biologists, chemists and computational biologists, both clinicians and basic scientists, from
academia and biotech. The venue and scientific program will foster interaction between participants with different
expertise and career stages. Previous evaluations have ranked this conference highly for outstanding
presentations, ample time for scientific interactions and discussions, collegial atmosphere fostering mentorship
and collaboration, and for the high impact speakers, who remain for the entire duration of the conference. We
are committed to increasing the number of abstracts selected from early career
researchers/postdocs/trainees/URMs and will provide a platform for short presentations, poster sessions and
sufficient free time to foster collaborations.
The 2024 program covers all major areas of high interest in the field of biological methylation such as
lysine and arginine methylation, DNA methylation and novel RNA methylations. These are particular relevant
fields of research given the recent promising clinical studies on several small molecule inhibitors in cancer
therapy. Other sessions will discuss the structure and function of RNA, DNA and protein
methyltransferases/demethylases, and their therapeutic targeting. During organized sessions at lunch,
attendees will have the opportunity to “Meet the Experts” and discuss “Career Development”. After the very
successful 2022 “Women in science” workshop, we will use a similar format that will be expanded to include
discussions about work/life balance.
To summarize, the specific goals of this conference are to: 1) Provide a forum for the presentation of
unpublished, cutting-edge research by investigators from diverse fields applicable to biological methylation, both
from academia and pharma; 2) Provide an opportunity for scientists studying diverse aspects of the biochemistry,
structure/function and disease relevance of methylation, to discuss recent research developments and to initiate
collaborations; 3) Ensure development and integration of young investigators from diverse backgrounds and
those traditionally under-represented in these fields into the broader research community.

Public health relevance
Project Narrative The goal of the 2024 FASEB SRC on Biological Methylation is three-fold: (1) To bring together members with diverse expertise to bridge and foster collaborations and translational research in the fields of cancer, neurology, developmental biology, and small molecule inhibitors; (2) To provide an opportunity for scientists studying diverse aspects of the biochemistry, structure/function and disease relevance of SAM-dependent methylation to discuss recent research developments and to initiate collaborations; (3) To provide a supportive mentoring platform for trainees and junior investigators from diverse backgrounds, giving them opportunity to engage with those more established in their field.